Genetic Variants Associated with HDL and LDL Cholesterol, and Triglyceride Levels

High levels of LDL cholesterol (LDL-c) and low levels of HDL cholesterol (HDL-c) are independent risk factors for coronary artery disease (CAD). During the mentored phase of this award, we have identified 59 novel regions associated with lipid levels (Teslovich et al., 2010). We are continuing our research to identify novel genes and genetic regions associated with lipid levels through several strategies, several of which are extensions to successful aims from the Mentored Phase of this award. We will continue to test for association in a GWAS framework by testing the most promising 5,000 genetic variants in 100,000 additional samples. We are also involved in the analysis ofthe Exome Sequencing Project of NHLBI which has completed whole exome sequencing of 417 samples, all from the upper or lower 1% tails ofthe LDL-c distribution. Identification of novel, highly disruptive genetic mutations may provide valuable clues about which gene in a potentially large region may be involved in lipid metabolism, a reversal of the typical paradigm to identify common variants in genes that contain rare disruptive mutations for related Mendelian disorders. For the independent phase of this award, experiments designed to understand the functional basis of previously identified genetic signals will be undertaken, including aligning genetic variants that play a role in lipid levels with position of known transcription factor binding sites from publicly-available Chip-Seq data. The final aim for the independent phase ofthe award is to use information from the 1000 Genomes Project to impute and test ~10 million SNPs for association with lipid levels, catalog associated variants in associated regions and refine signatures of long-range regulatory elements.

Public health relevance
RELEVANCE (See instructions): The identification of novel genes and functional elements associated with HDL-cholesterol, LDL-cholesterol and triglyceride levels is likely to have a significant impact on our understanding of the mechanisms of heart disease and has the potential to lead to new treatments.